Longitudinal Assessment of Cerebrovascular Autoregulation (CA) and Associations to Neurodevelopmental Delays in Infants and Toddlers with and without Congenital Heart Disease (CHD)

Significance Congenital heart disease (CHD) is one of the leading birth defects in the United States, affecting
approximately 40,000 newborns annually.1,2 Despite efforts aimed at prevention and early detection of poor
neurodevelopmental outcomes (NDO), many children with CHD will have neurologic deficits lasting into
adulthood.4,5 Surgical factors explain only 20% of these poor NDOs,6,7 leading to the examination of factors
intrinsic to CHD as the cause for poor outcomes. A hypothesis not extensively examined is whether impaired
cerebrovascular autoregulation (CA) is responsible for poorer NDOs in infants with CHD.8 Career Development
Goals My overall goal is to be an independent academic investigator creating strategies and interventions to
reduce or prevent developmental delays in vulnerable pediatric populations, such as those with CHD, thereby
improving their quality of life. This goal aligns with the National Institute of Nursing Research’s “Symptoms
Science” strategic plan because it seeks to understand the mechanistic pathways underlying developmental
delay in children with CHD. My career development plan is to: improve my knowledge of cardiovascular and
brain physiology in CHD and healthy infants; learn how to analyze CA using correlations of mean arterial blood
pressures with Near-Infrared Spectroscopy measures; acquire familiarity of statistical analyses of complex,
multilevel, time-dependent models; and enhance grant and manuscript writing skills. The environment at
Children’s Hospital Los Angeles and the University of Southern California have the support and infrastructure
necessary to complete my training and project. The mentoring and training plan of the K23 will help me discover
the mechanism of injury and may lead to treatments that improve CA, which will prevent or attenuate
developmental delays in high-risk children. Study Aims To assess CA in infants and toddlers with and without
CHD, and to evaluate the association of CA with NDOs at birth, 6, 9, and 18-months of age time points. Aim #1:
Compare CA between CHD infants and healthy controls through 4 developmental time points. Aim #2: Assess
the association of CA with NDOs in CHD infants and whether the association of CA with NDOs varies across
diagnostic groups (CHD vs controls). Methods This study is a prospective, longitudinal, 2-group cohort design.
We will enroll 64 infants at birth [± 2 weeks] (32 with CHD and 32 age- and sex-matched healthy controls to yield
50 with complete data after ~20% attrition over the 18-month follow-up). CA will be measured using posture-
induced changes in brain oxygenation. NDOs will be measured using standard age-appropriate tools, e.g., the
Bayley Scales of Infant and Toddler Development IV. Impact If the hypotheses of this study are supported,
impaired CA will be shown to be important determinants of poorer NDOs in CHD, and they will serve as new
targets for future preventive interventions to improve developmental outcomes in these high-risk children. Both
the knowledge of CHD infants at higher-risk for impaired CA and the early time points to intervene, will improve
lifelong NDOs in this vulnerable population.

Public health relevance
PROJECT NARRATIVE This study will contribute to the fundamental knowledge of brain injury and developmental delay in children with Congenital Heart Disease (CHD). The training and support of this mentored career development grant will facilitate my path towards an independent research career that aims to identify whether impaired cerebrovascular autoregulation is associated with poorer neurodevelopmental outcomes in infants with CHD. Identifying these mechanisms will provide the groundwork for future clinical interventions to reduce or prevent developmental delays in vulnerable pediatric populations.